Multi-tracer Magnetic Particle Imaging (MMPI): Tracer Design and Multi-tracer Guided Image Reconstruction

PROJECT SUMMARY
Multi-tracer medical imaging improves diagnostics by assessing multiple biological processes simultaneously,
providing a more comprehensive view of diseases like cancer, neurological disorders, and cardiac conditions.
While current magnetic particle imaging (MPI) offers excellent contrast and sensitivity, it is limited to single-tracer
imaging, which can only assess one physiological process at a time. Multi-tracer MPI (MMPI) faces technical
challenges due to the spectral overlapping of different tracers’ harmonics in the frequency domain (for system
matrix-based image reconstruction method) and the indistinguishable point spread functions (PSF) of different
tracers (for x-space image convolution method).
The goal of our proposal is to achieve MMPI by using customized tracers and a spectral-separation algorithm
for multi-channel, system matrix-based image reconstruction. The PI has demonstrated both theoretically and
experimentally a colorization algorithm that separates spectral signals from different tracers using a magnetic
particle spectroscopy (MPS) system. MPS is a 0D MPI system without selection or focus fields, creating a field-
free region (FFR) to characterize tracers. With successful spectral-separation, tracer harmonics can be divided
into separate channels, allowing the Kaczmarz algorithm to be applied for image reconstruction in each channel.
Using tracers with distinct magnetic properties, reflected in the differing shapes/slopes of their magnetic
hysteresis and Q-factors in the PSF, enhances spectral-separation accuracy and reduces channel leakage. Most
magnetic nanoparticle (MNP) tracers on the market have iron oxide cores, leading to similar magnetic properties
that cause significant channel leakage, and poor spectral-separation, thus, worsening MMPI performance. To
address this, we will design and customize cost-effective, rare-earth element-free, biocompatible spinel ferrite
MNP tracers with high magnetic moments. By doping divalent metals like Zn2+, Mn2+, and Mg2+ into Fe3O4, we
can alter the cation distribution and overall magnetic moments. The tunable magnetic properties of spinel ferrites
allow the creation of tracers with distinct magnetic hysteresis and PSF, which are expected to solve the MMPI
challenges for both system matrix-based image reconstruction and x-space image convolution methods.
Additionally, we will coat the tracers with red blood cell (RBC) membranes to further enhance biocompatibility
and prolong blood circulation time for potential in vivo applications.
For a preliminary demonstration of MMPI performance, we will 3D print magnetic phantoms containing multiple
tracers (N = 1, 2, 3, and 4) with varying tracer amounts, line widths, and gaps along the x, y, and z axes. These
phantoms are designed to assess spatial resolution in resolving multiple tracers in a single scan. The MMPI
demonstration will take place at our collaborator’s lab at NIST. A key advantage of this MMPI approach is its
compatibility with the existing MPI platform concerning signal collection and for each separated channel, the
traditional Kaczmarz algorithm can still be used for image reconstruction.

Public health relevance
PROJECT NARRATIVE The current magnetic particle imaging (MPI) technique, while offering exceptional image contrast and high sensitivity, is limited by its use of a single tracer, which only allows for the characterization of one physiological process at a time, preventing it from assessing multiple biological processes simultaneously and providing a comprehensive view of diseases such as cancer, neurological disorders, and cardiac conditions. The goal of this project is to demonstrate a multi-tracer MPI (MMPI) method that first separates the signals of different tracers into distinct spectral channels (spectral-separation), then applies the standard Kaczmarz algorithm to each spectral channel for image reconstruction, and finally combines the tracer images from each channel into one MMPI image. To enhance MMPI performance, the design of magnetic nanoparticle (MNP) tracers will be optimized for reduced channel leakage, improved spectral-separation accuracy, and increased biocompatibility, with performance tested on 3D-printed phantoms as a preliminary validation.